Modulation of Junctional Signaling by BVES in Colorectal Carcinoma

Colorectal cancer (CRC) has a U.S. incidence rate of almost 150,000 cases per year, encompassing over 10%
of new cancer diagnoses. In 2016, within the Veterans Administration Healthcare System alone, 3,400 new
patients were diagnosed with CRC, including 614 with advanced disease and very limited treatment options.
Understanding the basic biology of the underlying malignant transformation is the key to identifying new
therapeutic targets and intervention strategies. Epithelial junctional dysfunction is common in CRC. In early
iterations of this research plan, we discovered that BVES, a tight junction-associated protein, was
underexpressed via extensive promoter hypermethylation in colonic tumors, even at the earliest adenoma stage.
We and others have further demonstrated that restoring BVES expression attenuated pro-tumorigenic
phenotypes in a variety of cancer cell lines. In the prior funding period, we determined that BVES-deficient mice
had increased tumor burden and more severe dysplasia in both genetic and chemical tumor models. Collectively,
these data suggested that BVES functions as a tumor suppressor in epithelial malignancy; thus, BVES may
represent a new diagnostic marker and/or therapeutic target in cancer. Mechanistically, we are beginning to
understand that BVES functions as a scaffolding protein, orchestrating protein complex formation to facilitate
outside ® in signal transduction to coordinately regulate intracellular signaling pathways to alter cellular
phenotypes in response to microenvironmental cues. For example, we discovered that BVES interacts with
PR61a:PP2A to reduce cellular c-Myc levels and attenuate WNT signaling by restricting LRP6 levels. Recently,
BVES was discovered to modulate cAMP signaling in the heart. We determined that BVES interacts with
AKAP11, a cAMP/PKA nanodomain partitioning protein, and that BVES loss was associated with reduced PKA
activity as evidenced by reduced phosphorylated CREB. Thus, BVES likely regulates another signaling pathway
highly relevant to tumor biology. Lastly, we have established a bank of Stage II and III human CRC 3D cultures
and developed techniques to genetically modify and orthotopically xenograft them. This will serve as a platform
for testing whether BVES can modify the growth of established CRC and determining the relative contributions
of BVES-regulated signaling. In this proposal, we structure three Specific Aims designed to understand the role
of BVES in tumor biology. First, we will further our understanding of the BVES:AKAP11:PKA axis. In the second
aim, we will determine the functional impact of restoring BVES in early tumor biology (adenomas) ex vivo. In the
last aim, we will test the hypothesis that restoring BVES can attenuate the growth of human CRC and test
whether this restoring BVES sensitizes CRC to chemotherapeutic and targeted therapies in 3D culture and
murine models. Through these studies, we will gain fundamental insights into how BVES loss contributes
to malignant progression and extend our knowledge of how tumor-relevant pathways are regulated,
informing development of new diagnostics and therapeutics.

Public health relevance
Colorectal cancer remains the third leading cause of cancer-related mortality within the US and in veterans. Because of this, the VHA has issued specific directives (VHA Directive 2007-004) to improve CRC screening to detect CRC and remove pre-malignant polyps. Despite these improvements, approximately 3400 CRC cases are diagnosed yearly within the VHA system. Unfortunately, an average of 615 patients per year are still diagnosed at Stage IV, which has an overall poor prognosis. Thus, our proposed studies fit very well within the VHA cancer research portfolio. We aim to continue our VA-funded studies to understand how a novel protein, BVES, functions as a tumor suppressor in CRC. This line of research will deepen not only our understanding of BVES, but also our knowledge of the basic causes of CRC and how it advances. Our third specific aim is exceptionally clinically relevant, as we will test how BVES restoration affects tumor growth and response to treatment with traditional chemotherapy and targeted treatments in cultured human CRC and in animal models.